ENDOCRINE EVALUATION OF PANCREATIC TRANSPLANT

Type I diabetics undergoing pancreatic transplantation surgery are studied pre and immudiately post surgery. Longterm follow up includes these assessments: (1) study of the impact of physiologic regulation of glucose insulin kinetics and metabolic control, (2) study to provide date on endocrine markers to identify early rejection of the transplanted pancreas, (3) study of the endocrine responses to varoius stimulatory tests on denervated, systematically drained, pancreas preparation.